Dissecting the structure-function relationship of the Wnt destruction complex condensate

Project Summary
The Wnt signaling pathway has a peculiar molecular architecture: it relies on two large and highly disordered
scaffold proteins, APC and Axin, that assemble into a protein machine called the Destruction Complex (DC)
which regulates the interactions between pathway kinases, CK1α and GSK3β, and the transcriptional effector,
β-catenin. Mutations in either of the scaffold genes drive oncogenesis across a variety of deadly cancers (e.g.
colorectal, gastric, breast, melanoma, osteosarcoma) as well as diseases resulting from tissue dysbiogenesis
such as Hypertrophic Cardiomyopathy (affecting 1:500 people) and Congenital Hypertrophy of the Retinal
Pigment Epithelium (affecting 1-2% of populations of European ancestry). Despite the significance, we still do
not grasp the answers to basic questions regarding how the DC works–how is it organized, how do mutations
in these scaffolds lead to its dysregulation, and how should we treat scaffold mutations? In fact, there are
currently no FDA approved drugs that target the Wnt pathway. We propose a suite of experiments to determine
the structure-function relationship of the DC, taking into account our recent finding that the DC is a dynamic,
biomolecular condensate.
In our previous study we integrated advanced techniques for dissecting condensates, including
endogenous CRISPR tagging, super resolution microscopy, optogenetic reconstitution, and partial differential
equation models. These techniques enabled the detailed description of how changes in the organization of
these condensates can both accelerate and inhibit Wnt signals, which suggests how changes in DC scaffolds
can mechanistically lead to changes in Wnt signaling fidelity. Since then, we have used proximity labelling to
identify other potential DC regulators as well as observed aberrant DC morphologies that are caused by known
colorectal cancer-causing mutations in APC. Here we seek to (Aim 1) understand how DC-resident proteins
affect its structure and function and (Aim 2) understand how the DC is remodeled by oncogenic mutations in
APC. We employ a combination of fundamental biophysical experiments, geared towards uncovering the
organizing principals of the DC, along with directly-translatable lead generating experiments, to pinpoint
therapeutic targets specific to mutant APC cells. Overall, this research will significantly advance our
understanding of Wnt pathway regulation and its perturbation in cancer, potentially leading to precise treatment
options with fewer off-target effects that have plagued the failed attempts to drug the Wnt pathway as well as
enhancing our overall comprehension of condensate biology in disease contexts.

Public health relevance
Project Narrative This proposal aims to elucidate the regulators of the Destruction Complex (DC) structure and function in Wnt signaling and to determine the impact of oncogenic APC mutations on DC structure and function in colorectal cancer (CRC). By leveraging advanced techniques such as CRISPR-tagging, proximity labeling, and optogenetic reconstitution, we will identify potential therapeutic targets to correct aberrant condensate behavior and dysregulated signaling pathways. Our research has the potential to significantly advance our understanding of Wnt pathway dysregulation in cancer, leading to novel and precise treatment strategies for CRC and other Wnt-driven diseases.